Biology of the Lung: A Multidisciplinary Program

DESCRIPTION (provided by applicant): The goal of this program is to train scientists in fields related to lung diseases. We propose to accomplish this by providing formal course work, doctoral and post-doctoral degree programs, and laboratory based training in six major disciplines related to lung biology: Pulmonary Vascular biology, Developmental Biology of the Airways and Lung Vasculature, Lung Matrix Biology, Immunology and Inflammation, Genetics and Epidemiology of Lung Diseases, and Bioinformatics/Systems Biology. In this 6th renewal (31st year) we have developed a new comprehensive program in Systems Biology, building on our existing strengths in genomics and bioinformatics to add proteomics and an integrated approach to lung cell biology. In that regard, we have expanded the formal degree granting curricula and added outstanding senior faculty in Bio-informatics, genomics and proteomics and vascular biology to complement our existing programs. These new faculty interact with all our core disciplines to provide an integrated approach to Systems Biology of each research program. Predoctoral students in the M.D./PhD. Medical School Program, Biochemistry, Pathology, Immunology (either Microbiology or Pathology) and Engineering (Bioinformatics/Systems Biology) Ph.D. graduate programs are offered support for directed study through course work and thesis mentorship with Pulmonary Training Grant faculty. Post-doctoral M.D. trainees accepted into our Clinical Pulmonary Fellowship who express interest in pursuing careers in science participate in three to four years of research post-doctoral fellowship in one of the disciplines noted. During that time, they may elect any of three formal training programs: an M.P.H. degree program in Lung epidemiology or genetics sponsored by the School of Public Health;enrollment in our CREST program in translational medicine or a new Masters in Bio-Informatics. This renewal also provides a pathway to capture Ph.D. post-doctoral fellows who seek training in lung related biology. This award has trained over 60 doctoral students in Biochemistry, Pathology, Immunology and Engineering and 130 post-doctoral fellows over the past 29 years in disciplines related to lung diseases. Our graduates include 8 current or former Academic Chiefs of Pulmonary Medicine, three Chairs in Medicine, numerous Professors of Medicine and national leaders in every field of Pulmonary Science. (End of Abstract)